A soft electronics-enabled smart microneedle patch for neck pain management

Project Summary
Neck pain is a common cause of disability with 33.6 million disability-adjusted life years in the U.S. The
cost for neck pain due to production loss and sick leave are almost nine times higher compared to the
health care costs. However, neck pain is a relative understudied condition with no efficacious treatment
currently available. The first-line treatments are oral non-steroidal anti-inflammatory drugs (NSAIDs) to
decrease herniated disc induced inflammation, however, these oral treatments may cause gastrointestinal tract
ulcer/bleeding, liver and kidney injuries. Non-invasive patches can avoid the side effects of oral administration,
but often lack in efficacy due to limited drug penetration blocked by natural skin barrier—stratum corneum. Our
recent development of film electronics that allow to be integrated onto any surface provides an opportunity to
develop this electronic device controlled smart transdermal microneedle pain patch. In this project, we propose
to develop a wireless soft electronics enabled smart microneedle drug delivery patch to manage neck
pain by integrating electronic devices with thermo-responsive therapeutic microneedles. Successful completion
of this project will promote a multimodal patient-centered smart patch in reducing risk for GI upset and first-pass
metabolism of oral drugs and avoiding opioid addiction.

Public health relevance
Project Narrative Neck pain is a highly prevalent condition that leads to considerable pain, disability, and economic burden. Despite the clinical significance of neck pain, limited treatment options are available and often ineffective or unsafe. In this project, we will develop a wireless soft electronics-enabled smart transdermal microneedle patch to manage neck pain by integrating electronic devices with therapeutic microneedles.